J-RISE: Relevant Implementation Strategies to Eliminate the social and structural barriers to HIV services among Justice-involved Black men who have sex with men

Project Summary
Justice-involved Black men who have sex with men (BMSM) are particularly vulnerable to HIV, and oftentimes
experience delayed uptake and benefit from available HIV services. Status neutral interventions for justice-
involved BMSM are pertinent and urgently needed to address the social and structural barriers to HIV services
(e.g., unemployment) experienced by this population. Our collaborative has prioritized four status neutral
interventions (i.e., transitional case management [TCM], employment navigation [EN], contingency management
intervention [CMI], and employer outreach and support [EOS). Combining these interventions together will
maximize their independent effectiveness and provide significant promise for improving access to HIV and
employment-related services for justice-involved BMSM. We will utilize seven prioritized bundled implementation
strategies to support the adoption, implementation, and sustainability of status neutral interventions within
community and criminal justice settings. The overarching goals of the planned multi-site type 2 hybrid
effectiveness-implementation study, J-RISE: Relevant Implementation Strategies to Eliminate the social and
structural barriers to HIV services among Justice-involved BMSM is to simultaneously evaluate the effectiveness
and implementation of two packaged status neutral interventions within justice and community settings to
improve access to HIV and employment-related services. J-RISE is led by an academic, community, and criminal
justice collaborative and conducted in three Ending the HIV Epidemic (EHE) jurisdictions in Illinois and Louisiana.
Aim 1. Evaluate the effectiveness of two packaged status neutral interventions (TCM versus TCM+EN+CMI) on
primary outcomes (linkages to HIV care, PrEP care, and employment-related services within 90 days) and
secondary outcomes (receipt of mental health and substance use services, retention in HIV care, viral
suppression, PrEP persistence, and sustained employment) among justice-involved BMSM.
Aim 2. Evaluate the bundled implementation strategies and implementation outcomes at multiple levels using
CFIR, RE-AIM, and MIPA. Key implementation outcomes include acceptability, adoption, costs, fidelity,
penetration, and sustainability. J-RISE will generate novel information about the utility of our chosen
implementation strategies as well as critical information about the effectiveness and cost of packaged status
neutral interventions to optimize HIV and employment-related outcomes for justice-involved BMSM in multiple
EHE jurisdictions.

Public health relevance
Project Narrative The proposed study will examine the implementation and impact of delivering two packaged status neutral interventions focused on enhancing access to HIV and employment-related services for justice-involved Black men who have sex with men in Illinois and Louisiana.